COBRE: RIH: THEME B: PATHOGENESIS OF GI TUMORS, GERD, ESOPHAGITIS, SUBTITLE:

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This project will hypothesize that the release of reactive oxygen species (ROS) and proinflammatory cytokines from inflammatory cells and/or metaplastic cells of Barrett's esophagus (BE) following exposure to acid exposure promotes the development of esophageal adenocarcinoma(EA).